Microflow time-resolved cytometry for FRET and fluorescent protein development

Summary This application requests supplemental support for the purchase of a fluorescence lifetime imaging microscope (FLIM). A new microscope of this type will significantly advance the aims of the project: R01GM129859 Microflow time-resolved Flow Cytometry for FRET and Fluorescence Protein Development. FLIM systems have unique abilities to image cells whereby the image is a rendering of the fluorescence lifetimes measured across cells at a high resolution. The fluorescence lifetime is the average time a fluorophore spends in the excited state; it carries a significant amount of information about the fluorophore such as the microenvironment, near-neighbor proximity, and movement of intracellular molecules. This will support the parent R01 project because the objective for this work is to design and adapt fluorescence lifetime flow cytometry onto a microchip platform for cell screening and eventual sorting. The aims will develop a novel microflow cytometer that will, when completely vetted, incorporate many unique features such as acoustic focusing of cells through microfluidic channels, multi-frequency measurements that give rise to multiple- fluorescence lifetime values per cell, and electro-optical design for eventual cell sorting based on fluorescence lifetime measurements. Concurrently with the design and construction of the microflow cytometer two major applications of this tool are planned/underway. These are 1) the quantification of Förster resonance energy transfer (FRET) events inside of mammalian cells, and 2) the enrichment of near-infrared fluorescent proteins based on photo-kinetic data. Therefore a microscope (FLIM) with the unique ability to measure fluorescence decay kinetics is essential for 4 reasons: 1) it will enable us to independently cross-validate our cytometry measurements thereby providing resolution and precision that are orders of magnitude greater for reliable optimization; 2) it will significantly enhance the collaborative applications that we are exploring with our novel cytometer and current aims; 3) it will greatly expand the applicability of our cytometer for other fields thus broadening the biomedical impact while supporting future grant applications; and 4) it will become a tool for training and development of students and collaborating faculty at New Mexico State University, a Hispanic Serving Institution.

Public health relevance
Narrative This application requests supplemental support for the purchase of a fluorescence lifetime imaging microscope (FLIM). This instrument will significantly advance the aims of project: R01GM129859 Microflow time-resolved Flow Cytometry for FRET and Fluorescence Protein Development. It will provide the ability to independently evaluate our developing lifetime cytometer and most importantly enhance the validation of the many biomedical applications under investigation for future R01 renewals and collaborative projects.